Biochemistry Core

PROJECT SUMMARY
The Biochemistry Core supports projects associated with the Center for Pediatric Research by providing
consultation and technical support for protein-protein interaction screening with BioID-based methods, as well
as multi-analyte detection. The Core will continue to perform BioID and similar methods as a cutting-edge
approach to screen for protein-protein interactions. The Core will continue to provide technical abilities and
services for multi-analyte detection and quantification of proteins. The Core will also aid in the preparation of
manuscripts and funding applications as they relate to the services provided. By providing these services in
house, the Core will directly interface with the investigators during experimental design, protocol establishment,
troubleshooting and execution as well as organize any further analysis outside of the Core. The purpose of the
Biochemistry Core is to support the goals of its users, namely independent scientists studying the basis of
pediatric health and disease and uncovering novel approaches to treatment. Through this purpose the Core will
continue to not only propel the work of Center and other independent scientists forward but will do so in a
sustainable manner for decades to come.